Development of quantitative EEG biomarkers for Smith Magenis syndrome

ABSTRACT
Smith-Magenis syndrome (SMS) is a neurodevelopmental disorder caused by either deletion of 17p11.2 or
mutations resulting in haploinsufficiency of the RAI1 gene located on 17p11.2. Common features of SMS
include cognitive impairment, motor delays, impaired speech/language, a characteristic behavioral profile, and
severe sleep disruptions. Recent preclinical studies have identified potential targets for therapeutic intervention
in SMS. The central goal of our work is to facilitate future clinical trials by defining quantitative EEG biomarkers
for SMS. Prior work has observed qualitative impairments in ~50-60% of SMS EEGs; this will be the first
quantitative study of SMS EEGs. We will retrospectively analyze overnight EEGs containing periods of wake
and sleep from children with SMS and age and sex-matched neurotypical controls. Using spectral analyses
and other quantitative methods, we will complete two Aims: (1) Test the hypothesis that low-frequency brain
rhythms are enhanced in SMS, and (2) test the hypothesis that sleep spindles are disrupted in SMS. This work
will determine whether quantitative EEG analysis can detect SMS biomarkers that may then be validated
prospectively prior to deploying in future clinical trial settings.

Public health relevance
PROJECT NARRATIVE Smith-Magenis syndrome is a neurodevelopmental disorder characterized by cognitive impairment, motor delays, impaired speech and language, and sleep disruptions. We will quantify EEGs from children with Smith- Magenis syndrome and age-matched neurotypical controls in order to develop biomarkers for future clinical trials.